Quantification of compartmentalized metabolism in eukaryotic systems

2. PROJECT SUMMARY ABSTRACT
Acyl-coenzyme A thioesters (acyl-CoAs) are evolutionarily conserved critical metabolic intermediates that
are made and used in distinct parts of the eukaryotic cell. In different sub-cellular compartments, acyl-CoAs can
be used to meet energy needs, act as signaling molecules, and serve as acyl-donors for post-translational
modifications (PTMs) of proteins. A major challenge remaining unaddressed in the field of bioanalytical chemistry
is the quantitation of the subcellular localized pools of these critical metabolites, especially between the
mitochondria, nucleus, and cytosol where the same metabolite can have distinct functions. We will overcome
this challenge in two aims, leveraging stable isotope labeling strategies, quantitative mass spectrometry,
pharmacology, toxicology, and unique cell biology models. First, we will quantify the kinetics and fate of major
carbon substrates for compartmentalized acyl-CoAs in cells and heart tissue. Second, we will quantify the effect
of perturbing compartment specific processes with histone deacetylase inhibitors, electron transport chain
inhibitors, and genetic models on acyl-CoAs, downstream metabolites, and compartment specific PTMs. This
project will allow the rigorous quantification of distinct compartments of metabolism, and thus, their quantitative
study and manipulation in normal and pathological processes where metabolism goes awry.

Public health relevance
1. PROJECT NARRATIVE In eukaryotic cells, metabolites are compartmentalized to distinct parts of the cell to exchange chemical energy, maintain redox balance, act as signaling molecules, and to meet the needs of proliferation. This research develops, validates, and then uses state of the art techniques to directly quantify metabolites in each part of the cell to understand how they change as part of normal cellular and pathophysiological states.